ZINC AND BACTERIOSTATIC QUALITY OF HUMAN MILK

To investigate the possible role of zinc as an antibacterial factor in human milk. To determine whether any observed effects of zinc are concentration related within a physiologic range of zinc in human milk.